700MHZ NMR spectrometer with cryogenically cooled probe

Project Summary
This is an application for the acquisition of a Bruker NEO console and 1H/19F-detect, 13C,15N-
decouple 5 mm EUZ cryoprobe to replace the nearly 20-year-old console and cryoprobe of the
existing 700 MHz NMR spectrometer in the shared-use University of Pittsburgh Department of
Structural Biology high-field NMR facility. The requested console and cryoprobe will enable
reliable acquisition of high-quality high-sensitivity spectra, both on purified biomolecules in
solution and labeled biomolecules in living cells. The instrument requested is configured with four
independent radiofrequency channels and includes the capability for high sensitivity detection of
19F, an area of increasing emphasis among our user group. The need for the state-of-the-art 700
MHz spectrometer is justified based on the cutting-edge biomedical research, most of which is NIH-
funded, conducted by multiple investigators, and cannot be supported by the existing lower field
NMR instruments nor the only other high-field instrument dedicated for biomolecular NMR in the
greater Pittsburgh area, a nearly 20-year-old 800 MHz spectrometer that is experiencing an
increasing number of failures. The proposed state-of-the-art 700 MHz spectrometer will provide
capabilities for structural and dynamics analysis of a wide variety of biological systems and will
enable the investigators of this proposal to carry out their current NIH-supported research and to
take the existing projects to a new level. The spectrometer will also be critical for training PhD
students, most of whom receive their training through the joint University of Pittsburgh/Carnegie
Mellon University Molecular Biophysics and Structural Biology Graduate Program. Finally, having
this resource on campus will permit us to generate new collaborations with institutions in the State
of Pennsylvania and beyond, to attract talented new investigators at all ranks to the University of
Pittsburgh, and to train the diverse population of graduate and postdoctoral researchers for the
biomedical work-force in the interdisciplinary fields of structural biology, biophysics, and biomaterials.

Public health relevance
The requested console and cryoprobe to modernize our existing 700 MHz NMR spectrometer will enable detailed studies of complex biological macromolecules in solution, including their structures, dynamics, and interactions with other macromolecules and drugs. The information that emerges from these studies will reveal fundamental new information about complex biological macromolecules and will enable the design of novel drugs for the treatment of diseases, such as neurological disorders, HIV-AIDS, cancer, and drug resistant bacterial and fungal infections.